The Kansas Department of Agriculture's Maintenance and Enhancement of existing ISO/IEC 17025 Accreditation

Project Summary The Kansas Department of Agriculture aims to help create a national, fully integrated food safety system by maintaining our existing ISO/IEC 17025:2017 accreditation. The Kansas Department of Agriculture Laboratory (KDAL) serves as the primary testing lab for the Food Safety and Lodging (FS&L) program and is an integral part of the enhancement of surveillance and environmental sampling program. Continued laboratory accreditation to ISO/IEC 17025:2005 will allow for a complete quality system to ensure defensible analytical results are put forth. The accreditation attests to the competency and technical capabilities of a laboratory to perform certain tasks and supports traceability of data generated. The collaboration between FS&L and KDAL will play an integral role in achieving an integrated national feed safety system.

Public health relevance
Project Narrative Relevance By participating in this cooperative agreement, the Kansas Department of Agriculture Laboratory (KDAL) aims to successfully expand their scope and maintain their existing ISO/IEC 17025 accreditation. Additionally, the Kansas Department of Agriculture Laboratory (KDAL) will continue with their existing quality system consistent with the principles and requirements of ISO/IEC 17025:2017. The standard will attest to KDAL’s competency and technical capabilities to perform tasks and support traceability of data generated. Additionally, this cooperative agreement will allow for the enhancement of the Food Safety and Lodging program’s surveillance of manufactured foods and environmental sampling of processing facilities. Moreover, it will strengthen the relationship between the laboratory and the regulatory program. By expanding the existing surveillance program KDA aims to ensure a safer food supply for the State of Kansas.